Role of the ETS1 proto-oncogene protein in polyomavirus transcription

Project Summary/Abstract:
Polyomaviruses (PyVs) are common in the human virome, but in immunosuppressed individuals can cause a
variety of human diseases, including loss of transplanted kidneys, progressive multifocal leukoencephalopathy
(a brain demyelinating disease), and human cancers (such as from MCV, and recent studies indicating that the
common PyVs, BKV and JCV may also be causing cancers in immunosuppressed patients). The major PyV
oncoprotein is Large Tumor-antigen (LT). LT plays many roles in viral infection: genome replication, viral
transcriptional regulation, and directly targeting cellular growth suppressors. In addition, LT upregulates many
cellular genes required for the proliferative phenotype important for successful viral infection. LT-dependent
transcriptional upregulation does not require LT binding to DNA, but rather LT acts as a bridging factor
between cellular DNA-binding transcription factors and the cellular TBP/TFIID complex, which then recruits
TFIIB and RNA polymerase II. This explains why LT is capable of upregulating so many genes in a manner
that is independent of viral LT DNA binding sites. Here we show for the first time preliminary data that the
important cellular proto-oncogenic transcription factor, Ets1, is associated with LT, and furthermore, that
downregulation of Ets1 abrogates viral transcriptional activation by LT. In this proposal we will investigate the
mechanisms by which LT and Ets1 cooperate to regulate viral transcription, and the role Ets1 plays in the PyV
viral life cycle. These studies will provide insight into understanding how a major cellular proto-oncogenic
transcription factor, Ets1, is recruited and utilized by PyVs for transcription during their viral life cycle. These
studies will provide information that will lead to future studies on how the viral LT protein works with Ets1 to
produce changes in the cellular transcriptome required to create a hospitable intracellular environment for PyV
infection. As Ets1 exerts major global transcriptional effects important for the proliferative phenotype for the
majority of human cancers, these studies may also lead to future important insights into the transcriptional
roles of LT for cellular transformation and the induction of PyV-induced cancers.

Public health relevance
Project Narrative: Polyomaviruses cause various human diseases and cancers and encode a major regulatory protein Large Tumor-antigen (LT), which targets several cellular tumor suppressor proteins and is required for the transcriptional activation of both viral transcription as well as many cellular genes involved in creating a cellular phenotype supportive of viral proliferation. The mechanisms of LT-dependent transcriptional activation are not fully understood, but we show here that the cellular proto-oncogenic transcription factor, Ets1, is associated with LT and is required for LT-dependent transcriptional activation. In this proposal we will investigate how Ets1 participates in LT-dependent activation of viral transcription and affects the viral life cycle.